Administrative Supplements for Equipment Purchase: The Temperature-Controlled Incubator

Project Summary
Under the current NIGMS R15 research award (1R15GM147857-01), this proposal requests
supplemental equipment funds that will be used to replace an 11-year-old broken incubator for
the cultivation of our genetic model system (C. elegans). The parent project focuses on the
Proteolytic Regulation of Centrosome Proteins. The requested equipment is essential for
carrying out the experimental plans for the genetic and molecular analyses using the in vivo
model system. This administrative supplement fund will allow us to purchase a temperature-
controlled incubator to precisely monitor the temperature-sensitive effects of mutant strains. This
new imaging system will replace a broken incubator, which will serve a critical role in the success
of the parent R15 project.

Public health relevance
This application is for an administrative supplement to the parent R15 research award (1R15GM147857-01). We request supplemental funds to purchase the Biological Incubator (Model I-36NL, Geneva Scientific) to replace the broken incubator, which is essential for completing the parent project. The successful completion of this project will help further our knowledge of centrosome biology and cell division in humans with broad and important healthcare related to human cancers, ciliopathies, and developmental defects.